Dissecting cell composition and drug sensitivity in human adenoid cystic carcinomas (ACCs).

Adenoid Cystic Carcinomas (ACCs) represent one of the most common and biologically aggressive forms
of epithelial malignancy of the salivary glands, for which there are no clinically approved treatments. ACCs
are characterized by a high tendency towards peri-neural infiltration and distant-site metastasis, and are largely
refractory to conventional chemo-radiotherapy approaches. ACCs are also defined by a distinctive biological
feature: the co-existence within malignant tissues of two phenotypically distinct sub-populations of cancer cells
(ductal-like vs. myoepithelial-like) characterized by profoundly distinct gene-expression profiles and functional
properties. This study will leverage a portfolio of surface markers recently identified by our laboratory that
allow, for the first time, the differential purification, molecular study and functional analysis of these two cell types.
The hypotheses formally tested by this study are: a) that the two cell types co-exist in a dynamic and hierarchical
equilibrium, whereby one cell type functions as a progenitor for the other; and b) that biochemical pathways
regulating the conversion of one cell type into the other can be leveraged to develop new therapeutic approaches
against ACCs. The project envisions two specific aims: 1) to elucidate the developmental relationship
between the two cellular components of ACCs: we will use fluorescence activated cell sorting (FACS) to
purify the two sub-populations of cancer cells from human ACCs, and then employ prospective in vivo
xenotransplantation experiments and single-cell RNA-seq technologies to test whether the two cell types: a)
display robust and systematic differences in tumor-initiating capacity across patient-derived xenograft (PDX)
lines from independent patients; b) are hierarchically related (i.e. whether both can plastically inter-covert into
each other or whether one serves as the progenitor of the other, in a mono-directional fashion); c) contain
additional, previously unrecognized cellular sub-populations, themselves characterized by distinct molecular and
functional properties; 2) to test the in vitro and in vivo therapeutic efficacy of novel drug combinations
against ACCs, designed to target biochemical pathways shown to affect the differential representation
and preferential survival of the two cellular sub-types: we will treat 3D organoids and PDX lines shown to
recapitulate the dual cell composition of primary ACCs with sequential drug regimens, designed to, in a first step,
induce the differentiation of myoepithelial-like cells into ductal-like cells and, in a second step, to selectively
eliminate ductal-like cells; such novel drug regimens will be tested for their capacity to: a) cause changes in the
cell composition of malignant tissues (ductal/myoepithelial cell ratio); b) reduce tumor size and/or growth kinetics;
c) prevent in vivo metastatic dissemination (using non-invasive bio-luminescent reporters). Significance. This
study will elucidate the molecular and functional properties of the two cell types found in human ACCs, filling a
major scientific gap in salivary tumor biology, and addressing an unmet clinical need in salivary gland oncology:
the identification of novel drug targets for the pharmacological treatment of ACCs.

Public health relevance
Adenoid Cystic Carcinoma (ACC) is a deadly and drug-resistant form of salivary gland cancer, for which there are no clinically approved treatments. The goal of this project is to harness the knowledge recently generated by our laboratory to achieve two specific aims: 1) to understand whether the two major sub-types of malignant cells found to co-exist within this form of cancer (i.e. ductal-like and myoepithelial-like cells) are hierarchically related (i.e. whether one can serve as the progenitor to the other as a result of an epigenetic differentiation process akin to those observed in stem cell systems); and 2) to test the anti-tumor efficacy of new pharmacological approaches able to modify the relative ratio and preferential survival of the two populations. The results of this study will contribute critical knowledge about the basic biology of human ACCs, and will be used to design more effective drug combinations for their treatment, with important long-term benefits for the survival and quality of life of the many patients affected by this disease.